Molecular approach to ameliorate the age-dependent loss of Clock protein Bmal1 and Nrf2-antioxidant response in eye lens: Implications for eye lens health span

Abstract
In age-related cataracts (ARC), increasing levels of oxidative stress due to dysfunction of Nrf2 (NFE2-related
factor)-mediated antioxidant defense is widely recognized, but much remains unexplored. Nrf2 is known to
extend health/life span by maintaining redox homeostasis. However, with advancing age Nrf2 antioxidant
function deteriorates, resulting in etiopathobiology. A better understanding of the molecular regulation of the
age-dependent dysfunction of Nrf2-antioxidant pathway and its link to aging-related pathobiology and thereby,
finding the way(s) to ameliorate the Nrf2-antioxidant pathway can offer an opportunity to prevent ARC.
Recently, our in-vitro/in-vivo/ex-vivo studies with aging lens/lens epithelial cells (LECs) discovered that the anti-
aging drug, Metformin (Met) is efficacious in activating the deteriorated Nrf2/ARE (antioxidant response
element) antioxidant pathway via AMPK activation, resulting in lens/LECs protection. Notably, we identified that
Nrf2 and antioxidant genes, like Prdx6, can be synergistically activated via Bmal1 (brain and muscle Arnt-like
protein 1)/E-Box and Nrf2/ARE activities. Pursuing this line, we found that Met negatively regulates both the
expression/activity of BTB and CNC homology 1 (Bach1), an inhibitor of Nrf2 at ARE site(s), and revives
Nrf2/ARE pathway. Preliminary data also showed that Bmal1 or Nrf2 deficiency and increase of Bach1 levels in
aging lenses/LECs attenuate the Nrf2/ARE pathway. We envisioned that with aging, within the eye lens,
increased oxidative stress due to deterioration of Bmal1/Nrf2/ARE pathway creates a toxic milieu promoting
disease state, ARC. The molecular pathways underlying this process, however, remain elusive. Using Met as a
tool, the overall goal of this proposal is to determine the mechanisms underlying dysregulation of the
AMPK/Bmal1/Nrf2/ARE axis gene networks axis in aging eye lenses/ARC, and to examine the transcriptional
reprogramming of this axis and its contribution in abating aging pathobiology in response to Met by using state-
of-the-art RNA-Seq with biochemical approaches. Our initial data using each of these factors also showed that;
(i) Bach1 overexpression inhibits Nrf2 activation of antioxidants transcription, while Met treatment revives the
process; (ii) Cotreatment with an AMPK inhibitor blocks Met activation of Bmal1/Nrf2/ARE pathway; (iii) Met
instillation in aging mice eye, retards the lens pathobiology in-vitro/ex-vivo/in-vivo. These promising data
support the hypothesis that the dysregulation of Bmal1/Nrf2 gene networks can be revived by Met. We will
test the hypothesis via three specific aims: (1) Uncover the causes and the mechanisms of Bmal1/Nrf2
antioxidant pathway dysregulation in aging/oxidative stress in vitro. (2) Determine the mechanism(s) of Met-
mediated revival of Bmal1/Nrf2/antioxidant pathway and other target genes, and attenuation of lens opacity in-
vitro. (3) Determine the mechanisms underlying Met-mediated activities in preventing lens opacity in a mouse
model(s) of ARC in-vivo. The mechanisms of pathological signaling and role of Met uncovered in this proposal
should have a translational impact on increasing aging-related blinding diseases and improving public health.

Public health relevance
PROJECT NARRATIVE Because of increases in age-related blinding diseases, issues of healthy aging and blocking age-related pathobiology are becoming pressing social and biomedical challenges. The Nrf2 (NFE2-related factor2) mediated antioxidant defense pathway is crucial for cytoprotection; its dysregulation leads to pathobiology and is associated with a number of age-related chronic diseases. Understanding the molecular mechanism by which Nrf2 signaling goes awry and defining the molecular mechanism of a small molecule (Metformin) capable of modulating/reactivating Nrf2 function may lay a foundation for mechanism-based therapy to treat or prevent aging diseases, including cataract.